Redox, Environmental, and Metabolomics: investigating Disease Yield (REMEDY)

This study aims to investigate the association between plasma volatile organic compounds (VOCs) and
oxidative balance scores (OBS) as potential biomarkers for cardiovascular disease (CVD) risk in patients
with substance use disorder (SUD). Using data from the National Center for Health Statistics (2000-2024)
involving 101,316 participants, we will calculate OBS and examine the correlations between OBS and
plasma VOC levels in individuals with and without SUD, as well as in patients with and without CVD. Our
hypothesis is that substance use increases VOC exposure, disrupts oxidative balance, and elevates CVD
risk. Additionally, we will explore the clinical significance of VOCs in relation to oxidative damage
biomarkers and their impact on CVD risk in SUD patients. Utilizing plasma samples from 800 patients at
our Center for Cardiovascular Diseases and Sciences, we will identify SUD cases and controls, measure
oxidative damage biomarkers (8-hydroxy-2'-deoxyguanosine (8-OHdG) and protein carbonyls), and
quantify VOC levels and oxidative stress biomarkers in plasma. We hypothesize that SUD increases VOC
levels, induces oxidative stress, and contributes to CVD risk. This research will create a comprehensive
data repository and generate preliminary data to support an R01 grant proposal. By leveraging
epidemiological data and clinical data, we aim to establish a centralized database for managing
information on plasma VOC levels, oxidative balance scores, oxidative stress biomarkers, and CVD risk in
SUD patients. The preliminary data will highlight a novel approach linking VOC exposure, oxidative stress,
and CVD risk, emphasizing the public health implications and potential for identifying new biomarkers and
therapeutic targets. This work aims to enhance our understanding of the interplay between environmental
exposures, substance use, and cardiovascular health, ultimately guiding future research and intervention
strategies.